The musculoskeletal cost of metastatic colorectal cancer

PROJECT SUMMARY
Colorectal cancer (CRC), in particular metastatic CRC is frequently accompanied by the development of
cachexia, a multi-organ wasting syndrome affecting musculoskeletal health. Cachexia is directly responsible for
worsened quality of life in cancer patients and for over 30% of all cancer-related deaths. We and others have
shown that cancer is accompanied by metabolic and genomic perturbations of the liver, and further, that CRC
liver metastases (LM) exacerbate musculoskeletal wasting. Unfortunately, there is no available cure for cachexia,
and investigations into how metastatic disease exacerbates musculoskeletal wasting are sparse; hence, there
is a critical need to identify targetable mediators of skeletal muscle and bone loss in advanced CRC. In this
regard, our preliminary findings suggest that FGF21, an endocrine hormone belonging to the fibroblast growth
factor (FGF) family of proteins, plays a causative role in cancer-induced musculoskeletal wasting. In our
preliminary studies, circulating FGF21 was elevated in CRC patients and in MC38 tumor hosts, which present
with losses of skeletal muscle and bone. Deletion of FGF21 from MC38 cells reduced myotube atrophy and
osteoclastogenesis in vitro and preserved musculoskeletal health in vivo. Though suggestive that FGF21 is
largely tumor-derived in CRC cachexia, we also found elevations of hepatic FGF21 in tumor hosts. Supporting
a causative role for host-FGF21 in the development of cachexia, muscle mass, muscle torque, bone mass and
bone strength were protected in FGF21 knockout mice bearing CRC. Of interest, mice bearing CRC LM, which
display exacerbated musculoskeletal wasting, also have heightened circulating FGF21, further linking FGF21 to
the development of cachexia. Follow-up studies also revealed greater FGF21 in hepatocyte-CRC mixed cultures
and in the livers of mice with advanced CRC, suggesting a role of FGF21 in tumor metastasization. Altogether,
these observations suggest a novel role of FGF21 in the development of cachexia in advanced CRC. The
objective of this proposal is to interrogate the FGF21-dependent effects in metastatic CRC-associated muscle
and bone loss. Our central hypothesis is that metastatic CRC exacerbates FGF21 production, which in turn
mediates musculoskeletal wasting in advanced CRC. In Aim 1, we will investigate the FGF21-dependent effects
on bone loss in advanced CRC. The working hypothesis is that FGF21 determines bone loss in advanced CRC,
by promoting osteoclastogenesis. In Aim 2, we will determine the mechanism(s) by which FGF21 triggers muscle
wasting in advanced CRC. The working hypothesis is that FGF21 is participates in the development of muscle
atrophy. In Aim 3, we will examine the metastatic niche and its role in exacerbating CRC cachexia. The working
hypothesis is that tumor metastasization to the liver alters hepatocyte and cancer cell gene expression,
consistent with elevated pro-cachectic signaling and aberrant expression of FGF21. Completion of this study will
identify FGF21 as a novel therapeutic target for the treatment of musculoskeletal wasting in CRC and will
facilitate new avenues for cachexia research.

Public health relevance
PROJECT NARRATIVE Musculoskeletal wasting associated with cachexia affects up to 80% of patients diagnosed with advanced colorectal cancer, and equally impacts the quality of life in cancer survivors. By using in vitro and in vivo experimental models, we will identify new mechanisms underlying muscle wasting and bone resorption in contexts of liver metastases. This study will provide novel insights on the mechanisms of cachexia and identify FGF21 as a therapeutic target for the treatment of musculoskeletal wasting in advanced colorectal cancer.